Mechanisms of Staphylococcus aureus-induced changes in cutaneous T cell networks

Staphylococcus aureus (S. aureus) is a ubiquitous gram-­positive pathogen that is one of the
most frequent causes of skin and soft tissue infections. Frequently, these infections serve as a
prelude to invasive life-­threatening diseases. The prevalence of severe S. aureus infections
have increased in healthy populations, associated with the development of both drug resistance
and hypervirulence in methicillin-­resistant S. aureus (MRSA) strains such USA 300. The spread
of MRSA-­induced disease during training and mission assignments is a well-­documented threat
to military public health. A wealth of both clinical and experimental evidence suggests that (1)
neutrophils (PMNs) are essential mediators of anti-­S. aureus host defense, and (2) emerging
MRSA strains release toxins capable of killing PMNs, and consequently they can overwhelm
host defense responses and rapidly cause disease in immune competent individuals. The
rapidity of these events suggests a protective vaccine would be the best approach to disease
control. Using a model of healed MRSA skin infection that elicits protective immunity against a
second MRSA skin infection, we provide evidence that the appropriate induction of humoral and
cellular immune responses can separately but synergistically support anti-­MRSA effector
responses and expedite pathogen clearance. The research plan described herein will test the
hypotheses that active immunization against S. aureus is feasible, and that protective antigens
include secreted bacterial virulence factors. The specific aims are designed to evaluate the
pathogen and host-­derived factors that are required to initiate and maintain ant-­MRSA
protective adaptive immune responses. In specific aim 1 we will identify antigens leading to
protective immunity by systematically measuring the prophylactic effects of skin challenge with
selected knockout strains of MRSA followed by rechallenge with WT MRSA. In aim 2, we will
characterize T follicular helper and the germinal center responses that correspond with anti-­
MRSA protective immunity, and employ Langerin-­DTR mice to delineate the skin DC
requirements for these processes.
In aim 3, we will characterize the
cutaneous T cell signature
corresponding with anti-­MRSA protective immunity by measuring the kinetics and tissue
distribution pathogen specific T cells following infection with strains of MRSA that have been
engineered to express ova peptide OVA
323-­339. After clarifying the adaptive T cell correlates of

anti-­MRSA protective immunity, we will use the Langerin-­DTR system to elucidate the
underlying DC requirements for their induction. Overall the program is designed to dissect the
humoral and cellular immune components required for a protective immune response to MRSA.
Once explored, these data will provide the basis to design and evaluate approaches to a
preventive vaccine.

Public health relevance
Staphylococcus aureus (S. aureus) is one of the most frequent causes of skin and soft tissue infections. S. aureus infections often spread to internal sites and cause invasive life- threatening diseases. There has been an increase in severe S. aureus infections in healthy individuals, associated with the spread of drug resistant strains with heightened virulence mechanisms. Because of their rapid development, a protective vaccine would be the most effective way to prevent serious staphylococcal disease. We propose in this application to define the characteristics of protective immunity to S. aureus. In so doing, we will provide the needed background for design of a preventive vaccine.